Administrative Core

The Partnership for Native American Cancer Prevention (NACP) is an ongoing 22-year old collaboration between Northern Arizona University (NAU) and the University of Arizona Cancer Center (UACC), a National Cancer Institute-Designated Comprehensive Cancer Center. NACP will focus on cancer health outcomes in American Indian Alaska Native (AIAN) communities. The overarching goals and objectives of NACP are to reduce the cancer burden within AIAN populations through research and community engagement; expand the number of investigators working in cancer research, and increase the total number of investigators focused on studying cancer health outcomes in AIAN communities.
The NACP Administrative Core is the essential central component of NACP that brings together the inter-institutional leadership to administer, coordinate, and manage the U54 goals and aims. The Administrative Core ensures alignment, integration, communication, and transparency occurs between the respective Cores, Shared Resource, and research projects. The Core is responsible for NIH reporting, institutional accountability (including the interaction with the UACC Office of Community Outreach and Engagement (COE)), overall financial management, tracking of specific aims progress, processing Core and project evaluations, and facilitating the interactions and communications with the three advisory committees: Internal Advisory Committee (IAC), Program Steering Committee (PSC), and the Community Advisory Board (CAB).
The Administrative Core will also initiate recruitment of Early-Stage Investigators (ESI) focused on cancer health outcomes that will benefit AIAN and other Southwest communities. To ensure the success of NACP’s goals and objectives outlined throughout this application, the Administrative Core is charged with the following aims:

Aim 1. Engage a Partnership leadership team that integrates all the research projects, Cores, and Shared Resource activities in support of NACP goals and objectives, with a particular focus on supporting early stage investigators (ESI).
Aim 2. Provide administrative management for the entire Partnership including facilitating communication between Cores and research projects, fiscal management of all components, and community dissemination.
Aim 3. Coordinate the participation of the three advisory boards within NACP’s planning and evaluation activities and interface with NCI providing timely reports and responses to request for information.
Aim 4: Collaborate with the UACC Office of Community Outreach and Engagement (COE) to address cancer health outcomes throughout the Southwest.